Role for novel ventral tegmental area neuromedin S neurons in morphine responses

Summary
Although opioid dependence and addiction continue to constitute a major health and economic burden, our
limited understanding of the underlying neurobiology limits better diagnostics and interventions. Dysregulation
of the mesocorticolimbic reward circuit is acknowledged to contribute to various aspects of drug addiction, with
alteration in the activity and output of dopamine (DA) neurons in the ventral tegmental area (VTA) known to
contribute to the rewarding aspects of drug use. However, the molecular mechanisms underlying these changes
in VTA DA function remain relatively unexplored. Therefore, our overarching goal is to identify molecular
mechanisms in VTA DA neurons mediating long-term changes in drug reward that contribute to the persistence
of drug addiction. To this end, we used translating ribosome affinity purification (TRAP) to identify gene
expression changes in mice that specifically occur in VTA DA neurons following chronic morphine exposure.
While we found approximately the same number of gene expression changes by morphine in our input and VTA
DA fractions, our RNA sequencing analysis found very little overlap between these datasets emphasizing the
importance of this approach to identify mechanisms in VTA DA neurons as these are likely obscured in whole
tissue analyses. We have validated gene expression changes via qPCR and intriguingly, we find that expression
of number of neuropeptides not traditionally described in the VTA are robustly induced by morphine exposure.
Neuromedin S (NMS) was of particular interest as it was enriched in VTA DA neurons, and its expression was
robustly increased following chronic morphine exposure. While a role for NMS neurons has been described in
the suprachiasmatic nucleus in circadian regulation, NMS function outside this structure has not been
characterized, making it a highly novel gene of study. It is known that the primary receptor with which NMS
interacts, neuromedin U receptor 2 (NMUR2), is expressed within the target regions of VTA DA neurons, such
as the nucleus accumbens (NAc). However, whether all VTA DA neurons express NMS, and their potential
functional impact has yet to be determined. Thus, in this application we seek to characterize the expression and
functional impact of VTA DA neurons that co-express NMS via completion of three specific aims: 1) identify the
VTA DA neurons that express NMS and their projection sites, 2) determine whether modulation of VTA NMS
neuronal activity alters morphine-elicited behavior, and 3) determine if NMS knockout in VTA DA neurons alters
morphine-elicited behavior. Our studies will utilize cell type-specific CRISPR-mediated deletion to manipulate
the output of these novel VTA NMS-expressing neurons to assess their functional role in adult mice along with
transgenic mice and DREADDs to identify and alter VTA-NMS neuron activity. Critically, our new preliminary
data suggest that activation of VTA-NMS neurons affects morphine-elicited behavior, supporting the premise
and feasibility. These studies are expected to set the stage for future work investigating the role of specific VTA-
DANMS circuits, their activity during behavior, and their potential as targets for therapeutic intervention.

Public health relevance
Drug dependence and addiction continue to constitute a major health and economic burden and our inadequate understanding of the underlying neurobiology limits better diagnostics and interventions. The proposed studies will investigate the role of neuromedin s (NMS) neurons in the ventral tegmental area in morphine responses. These data will provide rationale for design of specific NMS pharmacological reagents, offering the promise that insights gained in these studies could lead to improved treatment of addiction, a high interest priority of NIDA.